Community-engaged research partnerships for building capacity and training in inclusive data science

PROJECT SUMMARY
Increasing diversity within STEM (science, technology, engineering, and mathematics) and the biomedical
workforce is prioritized by federal strategic plans. Federal efforts aimed at advancing equity call for
improvements in demographic data practices. While essential, our prior work documented that research
training programs for K-12 students remain challenged to accurately evaluate diversity and have requested
guidance around implementation and expanded reporting. Our prior work with equity-focused researchers and
STEM partners defined a set of expanded demographics that can more inclusively measure individual
identities. These demographics are currently being integrated into our previously developed informatics
platforms that deliver tailored research and education about health (Let’s Get Healthy!) and STEM
development (STEM Assessment and Reporting Tracker; START). The proposed project leverages data
visualization outputs from these informatics tools to surface conversations about demographic data collection
and responsible reporting with our cross-institutional partners representing STEM education, research, and
diverse communities. Inclusive demographics permit the identification of individuals who are being excluded,
marginalized, or improperly aggregated, thereby increasing capacity to address inequities in STEM and
biomedical research training. Together, this collaborative project aims to 1) identify considerations for inclusive
demographic data collection and responsible reporting; 2) establish a training collaborative that aligns
qualitative research with data science outputs to enhance authentic representation of a diverse biomedical
workforce; and 3) characterize how demographic data are used to make decisions and inform practice. This
project aligns interprofessional partners at roundtables to inform demographic data practices for use by STEM
programs. It offers multi-modal training of middle and high school students in research experiences that align
data science, qualitative research, and applied ethics for enhancing accurate and authentic representation of
identities. Finally, it builds the capacity of K-12 students and programs in inclusive data science, which become
transferrable research skills as students continue their careers. Our project enables STEM programs to
estimate prevalence and understand program impact for underrepresented populations, ultimately making
STEM evaluation easier for programs as we collectively work to improve STEM engagement and persistence
for diverse student groups. As trainees do not enter training programs with equal access, accommodations, or
preparation, inclusive demographic measures can inform a nuanced set of program outcomes, facilitating
research on intersectionality between demographic identities and supporting the recruitment and retention of
historically underrepresented students in biomedical research.

Public health relevance
PROJECT NARRATIVE This project builds capacity in inclusive data science for K-12 students and programs that support STEM (Science, Technology, Education, and Mathematics). Middle and high school students engage in research and interprofessional training that aligns qualitative research, data science, and applied ethics for enhancing accurate data collection and authentic representation of the biomedical workforce. This project applies iterative data feedback loops with collaborative partners to characterize responsible practices for collection and use of inclusive demographic data, which has the power to identify key demographic groups facing barriers to participation and retention in STEM programs needed to broaden and diversify the biomedical workforce.